Transcranial Magnetic Stimulation to Augment Behavior Therapy for Tics

PROJECT SUMMARY/ABSTRACT
Chronic tics affect 1-3% of youth in the US and are a disabling neuropsychiatric symptom associated with
multiple childhood-onset mental disorders. Tic suppression using Comprehensive Behavioral Intervention for
Tics (CBIT) is the current first-line, gold-standard therapy for tics. However, many patients do not fully benefit
from CBIT, likely because they lack the fundamental tic suppression ability that CBIT aspires to enhance. Our
preliminary data and the literature show that tic suppression ability can be enhanced with inhibitory repetitive
transcranial magnetic stimulation (rTMS) of the supplementary motor area (SMA). SMA is a key node of
cortico-striatal circuits and is known to be hyperactive and hyperconnected in tic disorders. We therefore
anticipate that combining CBIT with inhibitory stimulation of SMA may facilitate higher CBIT response rates.
This study will test whether augmenting CBIT with inhibitory, noninvasive stimulation of SMA normalizes
activity in SMA-mediated circuits and enhances tic suppression ability in young people with tic disorder. The
R61 phase will compare two rTMS regimens, 1 Hz rTMS and continuous theta burst stimulation (cTBS),
against sham stimulation. R61 aims will test engagement of brain (SMA-mediated circuits) and behavior (tic
suppression ability) targets and identify the optimal rTMS regimen. To this end, 60 youth ages 12-21 years with
chronic tics will complete 10 daily sessions of CBIT plus randomly assigned rTMS regimen, with fMRI,
behavioral, and clinical assessments before and after treatment. The R33 phase will investigate the effects of
CBIT augmentation with the optimal rTMS regimen in a double blinded randomized control trial in a new
sample of 60 youth with chronic tics. R33 aims test the link between target engagement and functional
outcomes, examine the clinical trajectory of the dose-response relationship, and assess intervention durability
at 1 month follow-up. TMS targeting in both phases will be informed by individualized electric field modeling.
This project will establish CBIT+rTMS as a treatment for chronic tics and provide a model for mechanistically
studying pediatric interventions combining behavior therapy with neurostimulation. Results from this line of
research will inform TMS therapy augmentation strategies and improve our understanding of neural
mechanisms underlying CBIT, TMS, and tics.

Public health relevance
PROJECT NARRATIVE Chronic tics are a disabling neuropsychiatric symptom driven by hyperactivity in brain circuits that include the supplementary motor area (SMA). Comprehensive Behavioral Intervention for Tics (CBIT) is the current first- line therapy for tics, but the majority of patients do not benefit from CBIT. This study will examine whether combining CBIT with inhibition of SMA using noninvasive brain stimulation (i.e., transcranial magnetic stimulation or TMS) normalizes activity in SMA-connected brain circuits, improves tic suppression ability, and enhances CBIT outcomes.